Molecular mechanisms of progranulin as a regulator of endothelial biology and blood pressure control

ABSTRACT
Endothelial cell (EC) dysfunction initiates the development of hypertension (HTN), but the mechanisms are not
fully elucidated. Given that HBP is the leading cause of cardiovascular diseases, it is critical to identify new
opportunities to restore EC function in HTN. In a series of supportive preliminary studies, we identified
progranulin (PGRN), an anti-inflammatory protein, as a novel regulator of EC function and BP.
We recently published that PGRN deficiency induces vascular dysfunction and HTN, whereas treatment with
recombinant PGRN (rPGRN) restores these cardiovascular outcomes via EphrinA2 and nitric oxide (NO)
production. In this proposal, we are extending our knowledge on PGRN and BP and identifying endothelial
PGRN as a new regulator of endothelial function and BP. In preliminary study, we show that Angiotensin II-
induced HTN selectively reduces PGRN in mesenteric EC, whereas mouse with a selective deletion of PGRN in
EC (PGRNEC Cre+) displays endothelial dysfunction, reduced circulating PGRN, and are more susceptible to
develop HTN. In further preliminary studies, we identified a new function of angiotensin converting enzyme
(ACE), which is to degrade endothelial PGRN and limits its vasodilatory function. These data suggest that
reduced endothelial PGRN, driven by ACE-mediate cleavage, is a trigger for EC dysfunction and HTN.
Mechanistically, we found that mesentery EC from PGRNEC Cre+ present suppressed AMP-activated protein
kinase (AMPK), while overexpressing PGRN in mesenteric EC resulted in exacerbated PGRN secretion followed
by AMPK activation and NO formation, which were blunted by blocking EphrinA2, suggesting that endothelial
PGRN regulates AMPK activation and NO formation via EphrinA2 in an autocrine-dependent manner. In further
preliminary studies, rescuing PGRN expression in mesenteric arteries ex vivo with rPGRN restored the
endothelial function in PGRNEC Cre+, but it failed to produce vasodilation in our novel double knockout mouse –
global PGRN deficient mice with lack of endothelial AMPK. We also demonstrated that AMPK is in oxidized form
in EC from PGRN deficient mice. Finally, Nox1-derived ROS are elevated in EC from PGRN EC Cre+, and that
pharmacological inhibition of Nox1 rescues the endothelial function in PGRN EC Cre+. These findings indicate that
endothelial PGRN maintains EC function and BP by restricting AMPK oxidation and Nox1 activity.
These novel findings inform the central hypothesis of this proposal: Endothelial PGRN, via an autocrine
mechanism, regulates endothelial function and BP and in HTN ACE degrades endothelial PGRN affecting its
bioactivity and contributing to cardiovascular outcomes. This hypothesis will be tested in the following aims:
AIM 1: Determine if reduced endothelial PGRN levels facilitate the genesis and progression of HTN via Nox1-
derived ROS, AMPK oxidation, and EC dysfunction.
AIM 2: Determine if ACE cleaves endothelial PGRN and contributes to endothelial dysfunction and HTN.

Public health relevance
NARRATIVE Hypertension is the leading cause of cardiovascular diseases worldwide. This study aims to investigate the role of endothelial progranulin and its autocrine actions on regulating endothelial function and blood pressure. By using cutting-edge technology such as genetically modified mice, gain and loss-of-function experiments, and best methods to study vascular function and blood pressure, we are expecting to place progranulin as novel therapeutic target for cardiovascular diseases associated with hypertension.